Development of Cochlear Innervation

Project Summary
The mammalian cochlea contains two types of specialized mechanosensors, inner and outer hair cells (IHCs
and OHCs), surrounded by distinct inner and outer supporting cell types and differentially innervated by afferent
and efferent neurons. The resulting structure and neuronal circuitry are critical for hearing. Our eventual goal is
to elucidate how this neural circuit assembles during development, and our overall approach is to alter the identity
of some of the cell types involved. In this proposal, by removing or adding the master regulator TBX2 at various
times in development we will generate mice with no IHCs and mice in which IHCs convert into ic-OHCs (inner
compartment outer hair cells, in the position of the IHCs but with most of the features of OHCs and not of IHCs)
at the time of our choosing, either permanently or reversibly. With these manipulations we will be able to address
many unanswered questions regarding how auditory neural circuits assemble, such as which cells direct type I
afferents to IHCs and their vicinity, what normally limits type II afferents to innervate only OHCs, what is the role
of afferents in dictating how and where efferents terminate, and what is the role of IHCs, their contact with type
I afferents, and their synaptic communication with them in the formation and maturation of the distinct subtypes
of cochlear afferents. Finally, we hope to elucidate whether the contact and formation of functional synapses
between IHCs and type I afferent neurons of the cochlear spiral ganglion is restricted to critical developmental
periods or may occur later in life.

Public health relevance
Project Narrative The cochlea contains two types of sound detectors, inner and outer hair cells, which play distinct roles in hearing and communicate with the brain via distinct channels, each made up of different types of neurons. Our work will help elucidate how the specific connections between the cochlear hair cells and these neurons are formed. Our results will add fundamental understanding of the development of hearing, and information critical for the restoration of hearing through regenerative therapies.